High-density microelectrode array

PI: Kiehl, Thomas R. , Regenerative Research Foundation, High-Density Microelectrode Array
SUMMARY/ABSTRACT
With this application, we request funding to procure the HyperCAM Alpha platform from 3Brain AG (Zürich
Switzerland). The HyperCAM Alpha is a multi-well, high-density microelectrode array system for observing and
stimulating in vitro electrophysiological activity in electro-active cell cultures, cell constructs, organoids, and
primary tissue samples. This instrument provides several key features: 1) high-resolution recording capability;
2) dynamic stimulation functionality, 3) a multi-well format; 4) 3D sensor options, and 5) sophisticated analysis
software. These features ensure its utility across a range of biological investigations to meet the high-throughput
and high-fidelity demands of our users and collaborators.
This submission addresses a significant unmet need in our institute and region, namely the ability to test
the functional impact of cellular interactions, genetic changes or of perturbagens on neural systems at scale.
The researchers identified in this submission (spanning five institutions) are engaged in the study of a wide range
of neurological disfunction from disease, aging, injury and developmental disorders. Placement of this instrument
will directly advance work in frontotemporal dementia, Alzheimer’s, vascular contributions to dementia, sex-
specific aging impact on cognitive function, tissue regeneration, spinal cord injury, brain development, and
disease impact on neurological development. This instrument will help to quantify model systems, such as brain
organoids, that have fast become the workhorses of the field. Projects described here also advance the
development of new, more capable, model systems and even of next generation MEA-related devices.
The primary, concrete, long-range benefit of this instrument to the biomedical research goals of
RRF/NSCI/NeuraCell is to provide routine, clear, high-resolution, easily captured, characterization and
quantification of the behavior and function of the numerous neurological systems under study at our institution.
The use of this instrument will be integrated into nearly every research program within our walls. Beyond our
organization, this instrument will: amplify the existing programs of our major users; help our minor users
establish and grow their related research programs; and endow a foundation for future technology
development.

Public health relevance
PI: Kiehl, Thomas R. , Regenerative Research Foundation, High-Density Microelectrode Array PROJECT NARRATIVE The proposed instrument, the HyperCAM Alpha, produced by 3Brain, enables researchers to observe the electrical signaling functions of neurons they are studying. Disease, aging, and developmental disorders can cause neurons to function improperly. This tool provides very clear, very high-resolution recordings of the activity of whole groups of cells allowing researchers to determine the causes and effects of a wide range of neurological diseases and disorders.